Biostatistics and Bioinformatics Core

PROJECT SUMMARY/ABSTRACT: BIOSTATISTICS AND BIOINFORMATICS CORE
The Biostatistics and Bioinformatics Core (BBC) will support all four full projects. Additionally, all Developmental
Research Program pilot projects and Career Enhancement Program applications will receive support from the
BBC. Detailed and specific biostatistical and bioinformatic analysis plans are provided for each specific aim/sub-
aim within each project. Sample size for each primary experiment is computed to provide high power to detect
clinically or biologically relevant effects. Each project will include RNA-seq data analysis and whole-exome seq
data analysis. For these high-dimensional data analyses, steps will be taken to ensure raw data quality; the
unified method described in the Research Strategy will be applied to assess quality of the sequencing data
before statistical analysis. BBC support is required for all Breast SPORE studies, with biostatisticians and
bioinformaticians from this core assigned to each project. Core personnel have worked and will continue to work
closely with project leaders to ensure the core provides state-of-the-art statistical/bioinformatic support.

Public health relevance
PROJECT NARRATIVE: BIOSTATISTICS AND BIOINFORMATICS CORE The relevance of the Biostatistics and Bioinformatics Core (BBC) lies in our provision of services essential for the conduct of high-quality collaborative breast cancer research. The BBC provides sound biostatistical and bioinformatic inputs throughout the lifespan of each research project, from conception to completion. To ensure the needs of the investigators are met thoroughly and efficiently, key biostatisticians and/or bioinformaticians are assigned to each project.